CD38, T cells and post viral lung sequelae during aging

Summary/Abstract
In light of the widespread and devastating impact of the SARS-CoV-2 pandemic, a significant number of
individuals have been observed to develop chronic lung conditions characterized by persistent inflammation
and fibrosis after recovering from acute COVID-19. Furthermore, recent studies indicate that such chronic lung
issues are also prevalent following other respiratory viral infections, such as influenza. A critical gap in our
understanding persists regarding the cellular and molecular mechanisms that underlie the development of
chronic lung sequelae post-primary viral pneumonia. This gap in knowledge poses a potential obstacle in
creating effective treatments for patients suffering from chronic lung fibrosis triggered by SARS-CoV-2 and
other respiratory viral infections.
Our research has revealed that CD8 tissue resident memory (TRM) cells exhibit high levels of the NAD+
ectoenzyme CD38. This enzyme is essential for the formation and maintenance of CD8 TRM cells after primary
respiratory viral infections. In this proposal, we aim to explore the hypothesis that targeting CD38 could
dampen aberrant CD8 TRM accumulation in aged hosts, thereby mitigating age-associated chronic lung fibrosis
following viral pneumonia. If our hypothesis is correct, the data generated in this study will not only provide
mechanistic insights as to how lung sequelae develop after viral pneumonia including COVID-19, but could
also pave the way for targeted immunotherapies aiming to preserve lung function after acute viral pneumonia
in the elderly.

Public health relevance
Narrative We hypothesize that excessive accumulation of CD8 TRM cells causes persistent lung inflammation and fibrosis following severe viral pneumonia including COVID-19 in aged hosts. Furthermore, we will test the hypothesis that targeting CD38 enzymatic function will attenuate post-viral lung fibrosis and preserve lung function following viral pneumonia during aging. The data generated in this study will not only provide mechanistic insights as to how lung remodeling develops after viral pneumonia, but would also point a direction for targeting CD38 to prevent or treat persistent lung conditions following influenza or severe COVID-19.